Georgia Center for Diabetes Translation Research

While considerable evidence is available for prevention and care of diabetes, huge gaps remain in accessible and sustainable translation of this knowledge into practice and policy in clinical and community settings. To close these gaps, the Georgia Center for Diabetes Translation Research (GCDTR), has leveraged the multidisciplinary expertise and experience in Atlanta, by bringing together collaborations among researchers from several leading institutions, namely, Emory’s Rollins School of Public Health, School of Medicine, School of Nursing, and Goizueta Business School; Georgia Institute of Technology; and Morehouse School of Medicine. Having successfully expanded the translation research (from $15 to $33 million annually), and investigators (from 38 to 102 members, including 26 newly recruited diabetes faculty) bases, GCDTR will embrace the vision of health for all and strive to close the gaps in diabetes prevention and care across demographic and comorbid groups, especially in socially, economically, and diverse populations. GCDTR will include an Administrative Core A, seamlessly coordinating three interconnected translation research cores: (1) Core B, Design and Evaluation, emphasizing measurement and learning from previous experiences—both successes and failures—through appropriate metrics and evaluation and innovating for the future (design) to help stimulate progress; (2) Core C, Socio-ecological and Behavioral Sciences, bringing a wealth of interdisciplinary experiences in developing theoretically-based interventions and innovative, technology-driven engagement methodologies promoting the adoption and maintenance of health- promoting behaviors among varied populations; and (3) a Regional Core, Technologies Advancing Translation, and expanding partnerships to include institution in neighboring Florida and Tennessee – southeastern states that have historically had large underserved areas and populations at high risk for diabetes. Enrichment and Pilot and Feasibility Programs will continue to enhance young and transitioning investigators’ capacity to be competitive for NIH funds in translation research and have impact on diabetes prevention and care. This multi-institutional, multidisciplinary center, involving over 120 members, brings considerable breadth and depth of research expertise, a substantial research base, and leverages several NIH-funded Centers, namely, the Georgia Clinical and Translational Science Alliance (GaCTSA), Center for AIDS Research (CFAR), and the AHA-funded Morehouse/Emory Center for Improving Health Across Communities. Proximity to and relationships with the Division of Diabetes Translation at the US Centers for Disease Control and Prevention (CDC) also offers GCDTR many unique assets. Furthermore, we have instituted several innovations, and obtained strong institutional support and commitments (totaling $857,500 over 5 years), and leveraged a variety of doctoral and post-doctoral programs to develop an efficient, effective, and integrated center.

Public health relevance
The Georgia Center for Diabetes Translation Research (GCDTR) advances the prevention and management of diabetes by accelerating the real-world application of proven interventions in clinical and community settings. Through interdisciplinary research, community engagement, and data-driven innovation, the Center supports improved health outcomes across populations. Its work delivers sustainable, scalable solutions that inform policy and practice to reduce the burden of diabetes locally and nationally.